LIGAND BINDING FUNCTION OF BETA INTEGRINS

Integrins are cell surface heterodimers that are composed of distinct alpha and subunits. Integrins mediate interactions with multiple extracellular and cellular ligands. Integrins are involved in cell migration, cell-cell interaction, development, tumor metastasis, wound healing and in the pathogenesis of many diseases. Integrin/ligand interaction is, therefore, a therapeutic target. We recently identified many structural elements of alpha and beta subunits of integrin involved in ligand binding and regulation. (1) A residue of Beta1 critical for ligand binding, (2) a regulatory epitope of Beta1, which is potentially involved in activation and inhibition, and (3) activation-dependent conformational epitopes of Beta1, which are induced upon activation of Beta1 integrins, (4) critical residues of alpha2 I domain for binding of collagen and echovirus-1, (5) a predicted Beta-turn of the third amino-terminal repeat of the alpha subunit as potentially critical for ligand binding of non-I domain integrins, (6) a putative laminin-5 binding site of alpha3, distinct from that of alpha4. To elucidate more structural basis of ligand/integrin interactions at the molecular level, we propose to (1) identify the regions or residues critical for ligand binding and ligand specificity of the non-I domain integrin alpha subunits using site-directed mutagenesis and recombinant integrin fragments. (2) Identify laminin-5 binding site of alpha3 subunit using site-directed mutagenesis. (3) Identify residues and regions of Beta1 that are critical for ligand binding and regulation to prove the hypothesis that an I domain-like structure is present in Beta1. These projects will facilitate understanding of the ligand/integrin interactions and help to design potential inhibitors/activators that modulate the interaction, which might be useful (e.g., for preventing metastasis, thrombosis, rejection on organ transplantation).